Multimodality Micro-Optical Coherence Tomography for Imaging the Functional Microanatomy of the Human Cochlea

PROJECT SUMMARY/ABSTRACT
Sensorineural hearing loss (SNHL), the most common sensory deficit worldwide, is caused by damage to the
fragile mechanosensory and neural structures of the human cochlea. The vast majority of SNHL remains
irreversible, in part because the current clinical tools for otologic diagnosis, surgery, and therapy cannot visualize
or provide functional information about the micron-sized cochlear cells and nerve fibers deeply embedded in a
patient’s dense temporal bone. Thus, there is an urgent unmet need for an imaging tool that can determine the
status of cochlear sensorineural cells to identify the underlying pathobiological defect, and ultimately determine
the receptiveness of these cells to emerging SNHL treatments such as gene or cell therapy. To address this
crucial challenge, we propose to significantly advance our existing intracochlear catheter that images
sensorineural cellular structure with a high-resolution, cross-sectional imaging technology termed Micro-OCT
(µOCT). Our proposed multimodality µOCT (MM-µOCT) technology will obtain improved images of cellular
microstructure and simultaneously acquired and co-localized images of metabolic activity through 1) dynamic
µOCT (DµOCT) imaging of intracellular motion and 2) metabolic autofluorescence imaging (AFI) of NADH/FAD.
In Aim 1, we will develop and validate MM-µOCT technologies (both DµOCT and AFI) on the benchtop using
mouse cochlear explants and whole excised mouse cochleae. Explants will be exposed to agents that simulate
oxidative stress or hypoxia occurring during noise-exposure, while whole cochleae from noise- or gentamicin-
exposed mice will be imaged in situ. In Aim 2, we will develop a flexible MM-µOCT endomicroscopic probe for
imaging the sensorineural cells of the human inner ear, which will be tested in non-human primates following
unilateral noise exposure. In parallel in Aim 2, we will develop clinical grade MM-µOCT system and probe using
a medical device design control process and will apply for an FDA IDE for conducting a first-in-human study with
this technology after the grant is over. Through this robust clinical translation strategy, we will create a minimally
invasive tool for determining the microanatomic/metabolic states of critical cells implicated in human SNHL. This
new capability will allow hearing loss treatments to be individualized and optimized, improving therapeutic
success rates and restoring hearing in many more patients than is currently possible today.

Public health relevance
PROJECT NARRATIVE To address a critical unmet need for diagnosing human hearing loss on an individual patient basis, we propose to develop and validate a multimodality intracochlear imaging system and minimally invasive probe that can detect the presence of individual sensorineural cells in organ of Corti and quantify their metabolic activity in vitro and in vivo. Research will follow a robust clinical translation strategy, creating and validating a benchtop imaging system in mice, developing an intracochlear probe that can be inserted into the inner ear, tested in non-human primates, and fabricating a human-use device that can be used in future clinical studies. This new tool has the potential to revolutionize the field by enabling a better understanding of sensorineural hearing loss, precise clinical diagnosis leading to more efficacious treatment, and the development of novel hearing loss therapies.